PARTIAL SUPPORT FOR THE FOOD FORUM

The Food Forum convenes scientists, administrators, and policymakers from academia, government, industry, non-profits, professional societies, and consumer groups on an ongoing basis to issues related to food (including safety, regulation, systems, nutrition, and health) and identifying approaches to address them.